Investigate MOF regulated epigenetic mechanisms of skin development

Project Summary
Epigenetic mechanisms, in particular the ones mediated by Histone modifications, have emerged as an
essential layer of gene expression control mechanism. In the skin, several Histone modifications such as
H3K27me3 and Histone deacetylase such as HDAC1/2/3 have been studied. These elegant studies have
not only provided novel insights into important functions of epigenetic mechanisms in the skin but also
established skin as an excellent model system to study epigenetic mechanisms in a spatiotemporally well-
defined tissue. However, our understanding of epigenetic mechanisms in the skin is incomplete. The
functions of numerous Histone marks and their associated modifying enzymes are unknown. Among them,
Histone 4 Lysine16 acetylation (H4K16Ac) is particularly notable for its key role in regulating chromatin
compaction. Structural and biophysical studies indicate that H4K16Ac plays an essential role in transcription
activation by influencing both nucleosome structure and interaction with chromatin-binding proteins.
H4K16Ac is catalyzed by the MYST-family lysine acetyltransferase MOF (also known as KAT8), which is
broadly conserved in fly, mouse and human. The function of MOF and its catalyzed H4K16Ac mark is first
studied in the fruit fly Drosophila melanogaster, where H4K16Ac mark is found to coat the male X-
chromosome and elevate transcription by two-fold tomediate sex dosage compensation. However, the
function of MOF and H4K16Ac is not limited to X-chromosome genes for dosage compensation. MOF and
H4K16Ac have been shown to control many genes involved in the regulation of embryonic stem cells, liver
development, pericyte development among many others in mouse and human. The overarching goal of this
application is to determine the role of MOF and H4K16Ac mediated transcriptional control in epidermal
development. During our preliminary study, we have discovered that genetic deletion of MOF causes severe
defects in epidermal adhesion, differentiation and morphogenesis. In thisapplication, we will elucidate
molecular mechanisms and cellular functions of MOF/H4K16Ac during epidermal development. We propose
to 1) investigate the role of MOF in epidermal development; 2) Determine the mechanism of MOF in
governing ciliogenesis and mitochondrial functions; and 3) Elucidate the epigenetic mechanism of MOF-
mediated gene expression control. Combining our expertise in mouse genetics, transcriptional and
epigenetic regulation, epithelial biology, genomics and computational biology, we will provide genetic,
genomic and molecular insights into a critical epigenetic mechanism governing mammalian skin
development.

Public health relevance
Project Narrative: In this project, we will determine the role of MOF and Histone 4 Lys16 acetylation in epidermaldevelopment. We will elucidate how MOF and the epigenetic mark control the expression of genes important for cilium morphogenesis and mitochondria. Knowledge gained from the proposed studies will help to establish a new transcriptional and epigenetic mechanism during mammalian skin development.